ADMINISTRATION CORE

TBD

Public health relevance
The proposed Center for Transport Oncophysics (CTO) desires to understand the physics of mass transport within a cancer lesion and mass exchanges between cancer and surrounding host biology. Once such mechanisms are understood, the CTO hopes to develop and improve cancer diagnosis and treatment. With improved cancer diagnosis and treatment, the burden of cancer will be lessened and the eradication of cancer oossible.